Demonstration and Implementation of Self-Collection for HPV Testing in a Federally Qualified Health Center System (UH2/3 supplement)

Project Summary Given current UH2/3 efforts to develop a cytology-free point of care diagnostic for cervical cancer screening, we propose the following supplement to efficiently answer novel research questions concerning the future introduction and implementation of a novel cervical cancer screening diagnostic into clinical care. For this proposed NCI supplement, we will conduct formative research to identify potential facilitators and barriers of offering HPV self-collection in federally qualified health centers (FQHCs) in North Carolina, United States. Specifically, we will evaluate health service delivery factors related to conducting electronic medical record (EMR) review to identify patients overdue for cervical cancer screening and providing HPV self- collection kits to these patients to increase cervical cancer screening. Aim 1: Identify key factors determining motivation and willingness of FQHC leadership and frontline clinical staff to implement an HPV self-collection intervention. Aim 2: Define health service considerations (logistical, organizational, and resource) for the successful implementation an HPV self-collection intervention in FQHCs. We will conduct focus groups among leadership and frontline staff at FQHCs. We will identify key implementation issues that emerge during focus group discussions and conduct semi- structured interviews with individuals at each participating FQHC who are most directly involved with these identified issues. These data will then be analyzed to evaluate health service delivery factors related to implementing the proposed HPV self-collection intervention.

Public health relevance
Relevance Few data are available concerning the health service delivery considerations of offering primary HPV screening by self-collection into federally qualified health centers (FQHCs) – centers that serve a high proportion of women at elevated risk of insufficient screening and subsequently of cervical cancer. This proposed supplement study will complement current UH2/3 efforts to develop a cytology-free point of care diagnostic by generating new data concerning potential facilitators and barriers of introducing a novel cervical cancer screening technology into clinic service delivery; results are expected to help shape future research and implementation of novel screening technologies within both global and domestic settings.